Acquisition of A MALDI-TOF Mass Spectrometer

DESCRIPTION (provided by applicant): The U.C. Davis Campus Mass Spectrometry Facilities (CMSF) is seeking funds to replace an 11 year old, obsolete AB 4700 MALDI-TOF/TOF. This instrument is used for high-throughput protein, peptide, glycan and oligo analysis by all our major users and is anticipated to soon be no longer supported by AB Sciex. The anticipated replacement instrument is a Bruker UltrafleXtreme. Seven major users and one minor user have been identified from the Departments of Chemistry, BioMedical Engineering, Animal Science, Med: Dermatology, Med: Hematology & Oncology and all are supported by NIH.

Public health relevance
PUBLIC HEALTH RELEVANCE: Research supported by NIH (and instrumentation in this proposal) involves a variety of health related issues including posttranslational modifications to proteins in mammalian systems, apoptosis and programmed cell death, the importance of glycoconjugates in human milk and development, oligosaccharides as antimicrobials, the design of imaging agents for enhanced drug delivery, and the design of improved imaging agents for the detection of cancer.